2022 Thalamocortical Interactions GRC and GRS

PROJECT SUMMARY
The Gordon Research Conference (GRC) on “Thalamocortical Interactions: Thalamic Architecture, Dynamics,
and Function in Health and Disease” will be held from February 6-11, 2022 at the Renaissance Tuscany Il Ciocco
Hotel, in Lucca (Barga), Italy. Participants from diverse backgrounds, areas of expertise, academic rank and
locales will come together at this conference to discuss and debate new findings related to thalamus and its
connections to cortical and subcortical networks; 150-200 attendees are expected. The meeting will be preceded
by a 2-day Gordon Research Seminar (GRS) organized by and for trainees to promote science communication
and mentorship, and to build community. The Aims are 1) To highlight recent developments and new areas of
thalamic research from the molecular level to whole brain function in health and disease; 2) To foster
collaborations among investigators at all career stages and in different countries, who have diverse areas of
expertise and are otherwise unlikely to have the opportunity meet, discuss, and generate new ideas; and 3) To
provide scientific and career development for trainees that promotes gender balance and diversity. Questions
addressed at this meeting include the role of thalamus in perception, initiating movement, determining behavioral
state (e.g. from sleep to arousal to engagement), global brain dynamics and how recent insights from the
laboratory translate to therapeutic practice. The speakers are at the forefront of their fields in science and/or
medicine and are instructed to present unpublished work, thus ensuring that the research discussed is cutting-
edge and timely. The program is tailored to demonstrate that scientific excellence and diversity can easily coexist
and to create mentorship opportunities for all trainees. The roster of speakers is fully balanced by gender and
includes ~12% participation of Black and/or Latinx speakers. Additional events include “Power Hour”, an
interactive venue designed to help all members of the community identify and dismantle career barriers that
women and underrepresented groups still face, and a memorial for a pioneer of thalamus research, Ray Guillery,
during which his life story (from refugee to Oxford professor) and contributions to the field are discussed. Each
day will also offer opportunities for informal interactions at poster sessions, meals, and other events. The overall
structure of the GRC creates a collegial atmosphere that is intellectually open and energizing, thus facilitating
the exchange of knowledge and ideas. To promote an inclusive environment, the GRC administrators identify
options for childcare and the site is ADA (Americans with Disabilities Act) compliant. Thus, the conference is
fine-tuned to foster new insights and collaborations and provide a wide variety of mentorship opportunities.
Expected outcomes are that participants will leave the conference with fresh ideas for their own and/or new
collaborative research that will advance the field, and that junior colleagues will forge lasting relationships with
investigators at all career stages to promote scientific and career development. Moreover, this conference will
provide an indelible example of how diversity, in its varied facets, and excellence in science go hand in hand.

Public health relevance
PROJECT NARRATIVE Thalamus is central to diverse brain functions from sensory perception, to initiating movement, to higher cognitive processing. The meeting connects the many fields of thalamus research and will bring together scientists and physicians from diverse backgrounds, areas of expertise and academic ranks to discuss and debate new findings related to thalamus and its interconnected networks in health and disease. Further, all facets of the conference are designed to incorporate gender balance and diversity with scientific and career development.